EPIDEMIOLOGY OF DEMENTIA AND OTHER NEURODEGENERATIVE DISORDERS

The Neuroepidemiology Branch and an international group of expert neuropathologists have developed neuropathologic criteria for diagnosis of progressive supranuclear palsy (PSP). The objective of the PSP study is to determine the neuropathologic spectrum of PSP and better distinguish it from other disorders. The reliability of neuropathologists in using these neuropathological criteria was tested. Prospective studies are underway to validate previously clinically proposed criteria and to develop a model of clinical diagnosis PSP and related disorders, using clinical material confirmed by postmortem examination. Vascular dementia is the second most common cause of dementia in the elderly. Analytic studies to determine risk factors for vascular dementia (VAD) and dementia of Alzheimer type(DAT) are being planned for performance in Argentina in a well-defined population. Although diagnostic accuracy is important in epidemiologic studies, most case-control studies on dementia do not have well-defined populations. Neuroradiological anatomic (MRI) and perfusion imaging (Tc99 HMPAO cerebral SPECT) studies useful to differentiate DAT from VAD will be used in our studies. In line with our focus to identify the pathogenesis of neurodegenerative disorders, we plan collaborative studies with the epidemiology group of the National Institute on Aging, to evaluate the role of documented head injury in the later development of DAT by the examination of World War II veterans.